Astrocyte regulation of cortical neurodegeneration in C9orf72 FTD/ALS

PROJECT ABSTRACT The GGGGCC (G4C2) hexanucleotide repeat expansion (HRE) in the first intron of the gene C9orf72, is the most common genetic abnormality associated with frontotemporal dementia (FTD) and amyotrophic lateral sclerosis (ALS). The disease pathogenesis ultimately leads to the concurrent degeneration of cortical forebrain and spinal motor neurons, and result in the clinical deficits of motor function and dementia. While the C9orf72- FTD/ALS disease pathogenesis has been well characterized in spinal motor neurons and a contribution of the observed neurodegeneration has been attributed to spinal cord astrocytes, there is little known about the pathobiology in cortical astrocytes and their role in cortical neurodegeneration, which is proposed to contribute to the dementia symptoms in this patient population. Here, we hypothesize that cortical astrocytes play an integral role in the non-cell autonomous disease pathology contributing to the degeneration of cortical neurons in C9orf72-FTD/ALS. To test this hypothesis, we will investigate hiPSC-derived C9orf72-FTD/ALS cortical astrocytes in monoculture and in co-culture with cortical neurons (Aim 1). We will characterize C9orf72- FTD/ALS hiPSC-cortical astrocytes by assessing astrocyte function and determine C9orf72 HRE-specific pathobiology. Furthermore, we will establish the relationship between cortical astrocytes and cortical neurons using co-cultures of control and C9orf72-FTD/ALS lines. The co-cultures will be assessed for changes in astrocyte function, neuronal function and viability, and C9orf72-disease pathobiology. In addition, we will examine transcriptomic alterations in the diseased hiPSC-derived cortical astrocytes (Aim 2). Transcriptomic profiles of the diseased and control cortical astrocytes in both monoculture and co-culture conditions will be generated using RNA-sequencing. In addition, we will analyze existing single nuclei RNA seq data already generated in the lab and identify overlapping candidate genes that are specifically dysregulated in cortical astrocytes in C9orf72-FTD/ALS patients and hiPSC lines. We will validate these candidate genes on the RNA and protein level in postmortem patient tissue samples via RNAscope and immunohistochemistry, respectively. Select validated top hits will undergo preliminary mechanistic validation through genetic manipulation of these candidate genes in the hiPSC in vitro model. These studies will for the first time elucidate the contributing role of cortical astrocytes in the neurodegeneration of cortical neurons in C9orf72-FTD/ALS, addressing the disease mechanisms of dementia in this spectrum disorder. Additionally, this work will provide novel opportunities for drug target identification with the hope of identifying novel therapeutics for the affected patient populations.

Public health relevance
PROJECT NARRATIVE In C9orf72 frontotemporal dementia (FTD) and amyotrophic lateral sclerosis (ALS) the disease mechanisms cause concurrent degeneration of forebrain cortical and spinal and cortical motor neurons, therefore resulting in the clinical deficits in cognitive and motor functions. In ALS, a contribution of the observed spinal motor neurodegeneration has been attributed to spinal cord astrocytes, but little is known about the role of cortical astrocytes and its regulation of cortical forebrain neurons. This research proposal aims to examine the regulation of cortical astrocytes in the disease pathology contributing to the neurodegeneration of cortical neurons in C9orf72-FTD/ALS and its subsequent contribution to cognitive impairment and dementia in this patient population.